Metformin as a Novel Chemotheraeutic Strategy for the Treatment of Endometrial Ca

DESCRIPTION (provided by applicant): My long-term goal is to become an independently-funded academic clinician-scientist, performing translational research to improve outcomes for women with gynecologic malignancies. As an MD/PhD, I have laboratory experience in molecular and cellular biology using human gynecologic cancer cell lines in vitro. I seek a K23 Mentored Patient-Oriented Research Career Development Award to expand my skills in translational clinical trials and obtain a Masters of Science degree in Clinical Research (MSCR). This multi- disciplinary K23 proposal uses established cancer cell lines and primary cultures from endometrial tumors, gene expression profiling, and a clinical trial, to assess metformin as a drug for endometrial cancer therapy. Endometrial cancer is the fourth most common cancer among women in the United States, and the death rate from this disease has increased by 227% over the past ten years. Obesity and diabetes are linked to higher recurrence rates and death in the common form of endometrial cancer (type I, or endometriod). I hypothesize that metformin will act as an mTOR inhibitor and be an effective chemotherapeutic agent for a disease so impacted by obesity and insulin resistance. To understand metformin's anti-tumorigenic potential, I will assess the effects of metformin on proliferation, apoptosis and expression of key targets of metformin cell signaling in four endometrial cancer cell lines and in primary cultures of human endometrial cancer cells. In parallel, I will evaluate the biology of endometrial cancer in obese and non-obese women through gene expression profiling to identify appropriate targeted therapies to pair with metformin, and I will assess synergy between these agents and metformin in vitro. Lastly, I will determine the effect of metformin on the endometrium of obese and diabetic women with endometrial cancer by comparing each patient's endometrial biopsy with their hysterectomy specimen following 2-4 weeks of treatment with metformin. The effect of metformin on proliferation, apoptosis and downstream signaling pathways will be explored in tissue specimens and correlated to our findings with cultured endometrial cancer cells in vitro. Therapy during this preoperative window allows us to evaluate safely the biologic effect of metformin on human endometrial cancer in vivo. The training, curriculum, mentoring and 75% protected research time provided by the K23 award will enable me to establish myself as a translational researcher and clinical trialist. Through the K23 award, I will acquire the skills and a body of work to compete successfully for peer-reviewed grant support and ultimately, my first R01. My overall hope is to see the results of my bench science lead to clinical trials and the development of therapies that have a significant impact on the lives of women battling gynecologic cancers.

Public health relevance
PROJECT NARRATIVE Obesity and diabetes have been linked to poorer survival and increased recurrence rates in endometrial cancer. We hypothesize that metformin will behave as a novel mTOR inhibitor and prove to be an effective chemotherapeutic strategy for a disease undoubtedly impacted by insulin resistance. Thus, the overall goal of this proposal is to investigate the potential benefit of metformin as a targeted therapy for the treatment of endometrial cancer. __SpecificAimsTextDelimiter__ RESEARCH PLAN 10. SPECIFIC AIMS Endometrial cancer is the fourth most common cancer among women in the United States and has been increasing in frequency secondary to an aging female population and changes in dietary and hormonal factors, with obesity as a major culprit. It is estimated that 42,160 new cases will be diagnosed in 2009, and 7,780 women will succumb to this disease [18]. Obesity, diabetes and insulin resistance are strong risk factors that drive the development of the more common type I (endometrioid) endometrial cancers. Unfortunately, obesity is not only a risk factor for developing endometrial cancer, but it is associated with an increased risk of death [19-21]. Obese women with endometrial cancer have a 6.25 increased risk of death from this disease as compared to their non-obese counterparts [20]. Metformin is an anti-diabetic medication from the biguanide class that is widely used as the first line treatment of type II diabetes. Recent epidemiological evidence suggests that metformin use lowers cancer risk and reduces cancer deaths among diabetic patients [22-24]. It is not known whether the underlying mechanism behind metformin's potential anti-neoplastic effects relates to the systemic action of this drug, by reducing circulating insulin levels, and/or a direct action on cancer cells. Little is known of metformin's effect on the normal or malignant endometrium, particularly its interactions with growth factors and growth factor receptors such as the insulin growth factor receptor (IGFR), estrogen receptor (ER) and progesterone receptor (PR) that are critical to normal uterine function. Metformin's immediate downstream target is AMP-activated protein kinase (AMPK), and its activation leads to regulation of multiple signaling pathways involved in the control of cellular proliferation, including inhibition of the mTOR pathway. Alterations in the mTOR pathway have previously been implicated in endometrial cancer carcinogenesis. PTEN is a negative regulator of this pathway, and loss of PTEN expression is one of the most prevalent molecular abnormalities associated with endometrial cancers, occurring in up to 83% of type I endometrial cancers [25-27]. The mTOR pathway is thought to be a promising target for endometrial cancer treatment, and mTOR inhibitors are already in clinical trials for this disease. Our preliminary data finds that metformin is a potent inhibitor of cell proliferation in endometrial cancer cell lines, and that this effect is partially mediated through inhibition of the mTOR pathway. In addition, treatment with metformin in combination with paclitaxel results in a synergistic anti-proliferative effect in these cell lines. Thus, metformin may have important therapeutic implications for endometrial cancer, a disease strongly influenced by obesity and insulin resistance, with potential mechanisms of action including mTOR inhibition and chemosensitization. Obesity and diabetes have been linked to an increased risk of mortality from endometrial cancer [19, 21], and patients after diagnosis are strongly encouraged to make lifestyle changes such as diet, weight reduction and exercise. Unfortunately, these lifestyle changes are challenging for patients, and pharmacologic intervention through metformin may be an innovative chemotherapeutic strategy to both treat endometrial cancer and improve outcomes for these women with the additional benefit of impacting insulin resistance. Thus, we postulate that metformin will emerge as an effective targeted therapy either alone or in combination with other chemotherapeutic agents in the treatment of endometrial cancer. The advantages of metformin therapy are low cost, oral route of administration and very little toxicity. The overarching goal of this K23 proposal is to investigate the mechanism of action of metformin in vitro using both endometrial cancer cell lines and human primary cultures of endometrial cancer cells and in vivo through the short-term treatment of endometrial cancer patients in a pre-operative window clinical trial. This work will ultimately culminate in a phase I/II clinical trial of metformin in combination with an additional therapeutic agent for women with advanced and/or recurrent endometrial cancer, based on findings from gene expression profiling and assessment of synergistic activity. Specific Aim #1: To assess the effect of metformin on proliferation, apoptosis and expression of potential key targets of metformin cell signaling in vitro. Studies will be performed in endometrial cancer cell lines and primary cultures of human endometrial cancer cells. Pathways to be studied include the AMPK, mTOR, ER, PR and IGFR pathways. We hypothesize that metformin will inhibit proliferation and induce apoptosis in both the endometrial cancer cell lines and freshly isolated human endometrial cancer cells. Treatment with metformin will result in phosphorylation of AMPK and subsequent inhibition of the mTOR pathway. ER, PR and PTEN status differ among these cell lines, and this may influence the magnitude of action of metformin on its downstream targets. Through negative feedback signaling, metformin may downregulate ER and IGFR and conversely, upregulate PR. The effects of metformin treatment will also be compared between human endometrial cancer tumors derived from obese, diabetic patients versus normal weight, non-diabetic patients in short-term cell culture. We predict that the combined attributes of obesity and diabetes will impact response to treatment with metformin, with a greater effect on proliferation, apoptosis and downstream signaling pathways seen among tumors from obese, diabetic patients. Specific Aim #2: To select appropriate combination therapies based on the biology of endometrial cancer in obese and non-obese women. (2a) To identify differentially expressed genes in type I endometrial cancer using microarray analysis to compare tumors derived from obese women and non-obese women. We predict that the gene expression profiles will differ between tumors derived from obese and non-obese women with endometrial cancer. This analysis will identify potential therapeutic targets between these metabolically distinct patient populations and ultimately, provide a scientific rationale for the use of specific chemotherapeutic agents to be used in combination with metformin. (2b) To determine the effects of metformin in combination with other targeted therapies on cell proliferation and apoptosis using endometrial cancer cell lines, based on the findings from Specific Aim #2a. Synergy between metformin and various therapies will be evaluated using the multiple drug effect/combination index (CI) value as calculated by the method of Chou and Talay [28]. We hypothesize that one or more combinations of metformin with a targeted agent will result in a synergistic interaction as measured by a CI of < 1 in these endometrial cancer cell lines. This relationship will be reflected by greater inhibition of cell proliferation through increased G1 cell cycle arrest and increased induction of apoptosis as compared to either agent used alone. The effects of metformin on its downstream signaling targets will be determined for promising drug combinations. Specific Aim #3: To determine the effect of metformin on the endometrium of obese and diabetic women with endometrial cancer by comparing each patient's diagnostic endometrial biopsy before treatment with metformin to their post-treatment hysterectomy specimen. Obese and/or diabetic women who are to undergo surgical staging for endometrial cancer will also receive short-term treatment (2-4 weeks) with metformin that will continue until the day prior to surgical staging. The effect of metformin on proliferation, apoptosis and downstream signaling pathways will be compared between pre-treatment endometrial biopsies and post-treatment hysterectomy specimens, and interpreted with respect to findings from Specific Aims #1 and #2. We hypothesize that treatment with metformin will result in a decrease in proliferative markers and an increase in markers of apoptosis in the endometrial cancer tumors. AMPK phosphorylation and inhibition of critical downstream targets of the mTOR pathway will be seen in the post-treatment hysterectomy specimens. Ultimately, although likely beyond the term of the K23, I plan to assess the efficacy and tolerability of metformin in combination with other relevant co-therapies, as directed by the microarray analysis and preclinical assessments in Specific Aim #2, in women with endometrial cancer in a phase I/II clinical trial. I anticipate that the training and research obtained with the support of this K23 award will provide me the knowledge to develop future NIH-funded translational clinical trials of metformin or other targeted therapies for endometrial cancer treatment, with the hope of individualizing care between obese and non-obese women with this disease.